Role of macrophages in pancreatic islet graft rejection

DESCRIPTION (provided by candidate): Pancreatic islet transplantation has emerged as a promising therapy for type 1 diabetes mellitus (T1D). Complete and persistent insulin independence has been accomplished during the first five to seven years after islet transplantation. However, long-term acceptance and survival of transplanted islets is currently limited mainly due to immune-mediated rejection and/or recurrence of autoimmunity. Extensive research efforts have been dedicated to understanding the molecular mechanisms underlying rejection of islet grafts by effector cells of the adaptive immune system. Emerging evidence also suggest a prominent role of the innate immune system in this process, either directly or through cross-talk with the adaptive immune system cells. Such evidence indicate that cross-talk between innate and adaptive immunity is mediated in part via soluble factors (e.g., cytokines, chemokines) produced by myeloid cells that promote recruitment of effector lymphoid cells to transplanted tissues. However, little is known about the cell-cell contacts that may take place between these two arms of the immune system within the grafts. In this application, we aim to establish the role of cell-cell contacts between graft-infiltrating macrophages and effector T lymphocytes in islet rejection. Our preliminary results showed that macrophages infiltrated islet grafts shortly after transplantation in both syngeneic and allogeneic recipient mice, but the number of infiltrating macrophages increased significantly in the allografts during progression of acute rejection. The results also showed that depletion of macrophages in allograft recipients delayed rejection. These results point to macrophage involvement in the initial inflammatory response after islet transplantation in both syngeneic and allogeneic grafts and to an active role during ensuing acute rejection of the allografts. We therefore hypothesized that local cell-cell contacts between macrophages and effector T lymphocytes promote conversion of infiltrating M2 macrophages, typically involved in wound healing and tissue remodeling, to M1 macrophages which subserve effector cell function in islet allograft rejection. To test this hypothesis, we will use our unique technological platform to perform longitudinal, non- invasive in vivo imaging of the immune cells within pancreatic islets after transplantation (Abdulreda et al., 2011). We will accomplish the objective of this application by pursuing the following three specific aims: (1) Macrophages are necessary for efficient islet allograft rejection~ (2) Infiltratng macrophages acquire M1 phenotype during acute rejection~ and (3) Macrophage M2/M1 conversion is mediated through local cell-cell contacts with T lymphocytes. The expected results from these aims will establish local cell-cell contacts within target tissues as a novel cellular mechanism underlying the active role of macrophages in pancreatic islet rejection. Importantly, this new concept will enable localized interventions to improve acceptance of transplanted islets and will minimize/prevent devastating systemic side effects associated with chronic immunosuppression. These findings will have implications in transplantation therapies in general, as well as in cancer and autoimmune conditions.

Public health relevance
PUBLIC HEALTH RELEVANCE: Limited long-term survival of transplanted pancreatic islets due to immunological responses after islet transplantation to treat type 1 diabetes remains a significant limitation in this promising therapy. The proposed research aims to establish local cell-cell contacts as a novel mechanism contributing to graft rejection. The central hypothesis in this application is that local contacts between graft-infiltrating macrophages and effector T lymphocytes promote (1) conversion of "good" M2 macrophages to the "bad" M1 phenotype and (2) the active participation of the M1 macrophages in islet allograft destruction after transplantation. We will test our central hypothesis using our new technological platform that allows non-invasive in vivo imaging of immune responses in real-time in the same islet grafts longitudinally. The results are expected to provide experimental evidence to support the role of local cell-cell contacts in macrophage involvement in pancreatic islet rejection. This will enable new interventions targeted locally against such cellular interactions to improve long-term survival of pancreatic islet grafts. Local intervention will also minimize/prevent devastating side effects associated with chronic systemic immunosuppression. Furthermore, validation of this new concept on the role of local cell-cell contacts within target tissues in promoting immune responses will have therapeutic implications in transplantation therapies and other conditions such as cancer and autoimmune diseases. __SpecificAimsTextDelimiter__ B. SPECIFIC AIMS Replacement of the insulin-producing beta cells through pancreatic islet transplantation has emerged as a promising therapy for type 1 diabetes (T1D). Exogenous insulin independence is accomplished by islet transplantation and persists during the first 5 - 7 years. However, long-term acceptance and survival of transplanted islets beyond this period is limited mainly due to immune-mediated rejection and/or recurrence of autoimmunity. Extensive efforts have been invested in studying the molecular mechanisms underlying the destruction of islet grafts by effector cells of the adaptive immune system. Emerging evidence also suggest a prominent role of the innate immune system in islet rejection, either directly or indirectly through cross-talk with the adaptive immune system. Experimental findings indicate that cross-talk between innate and adaptive immunity is mediated in part via soluble factors (e.g., cytokines, chemokines) produced by myeloid cells that promote recruitment of effector lymphoid cells to transplanted tissues. However, little is known about the cell- cell contacts that may take place locally between these two arms of the immune system within the grafts. Without this knowledge, our understanding of immune-mediated rejection of transplanted tissues is incomplete. Our long-term goal is to fully understand the interplay between the innate and adaptive immune systems during graft rejection. In this application, we aim to establish the role of local cell-cell contacts between macrophages and effector T lymphocytes within pancreatic islets during rejection. Our preliminary results showed that macrophages infiltrate islet grafts shortly after transplantation in both syngeneic and allogeneic recipients, but macrophage infiltration was significantly higher in allografts during progression of acute rejection in our in vivo model in the anterior chamber of the eye (ACE). The results also showed that depletion of macrophages in allograft recipients delayed rejection. These results point to macrophage involvement in the initial inflammatory response after islet transplantation and to an active role during ensuing acute rejection. We therefore hypothesize that local contacts between macrophages and effector T lymphocytes promote conversion of alternatively activated "homeostatic" M2 macrophages to classically activated "effector" M1 macrophages and their active involvement in islet allograft rejection. The rationale for the proposed research is that the obtained results will contribute a fundamental element to our base of knowledge about the mechanisms underlying the macrophage role in rejection of islet grafts. We have established a unique technological in vivo platform to conduct longitudinal, non-invasive imaging of immune responses within pancreatic islets with single-cell resolution (Abdulreda et al., 2011). Our previous results in the ACE also demonstrated typical immune responses during rejection of full MHC-mismatched islet allografts despite immune privilege (Abdulreda et al., 2011). Here, we will use the same approach to study the movement dynamics and local interactions between infiltrating macrophages and T lymphocytes within the islet grafts and monitor their effects on islet survival. We will test our central hypothesis and accomplish the objective of this application by pursuing three specific aims: Specific Aim 1: Macrophages are necessary for efficient islet allograft rejection. Our preliminary results showed prolonged islet survival in macrophage-depleted recipients. Islet rejection also occurred in CD8- /- mice or with CD3 blockade suggesting involvement of immune cells other than T lymphocytes. The working hypothesis in this aim is that macrophages are necessary to reject pancreatic islets timely and efficiently. We will test this hypothesis using our in vivo model by systematically manipulating macrophages and imaging (a) macrophage infiltration of transplanted islets and (b) monitoring survival of the islet grafts in real-time. Specific Aim 2: Infiltrating macrophages acquire M1 phenotype during acute rejection. Based on our preliminary data showing early infiltration of syngeneic and allogeneic islet grafts by macrophages followed by significant increases in allografts during rejection, we hypothesize here that early infiltrating M2 macrophages acquire an M1 effector phenotype during progression of acute rejection. We will test this working hypothesis in our in vivo model by injecting labeled antibodies directly into the ACE (i.e., "in situ immunocytolabeling") (Abdulreda et al., 2011) to establish in real-time the phenotype(s) of graft-infiltrating macrophages at different time points. We will also block IFN-gamma receptor by specific blocking antibodies and (a) image survival of the islet grafts and (b) determine the proportion of M1 vs. M2 macrophages in the same grafts longitudinally. Specific Aim 3: Macrophage M2 to M1 conversion is mediated through local cell-cell contacts with T- lymphocytes. Our preliminary studies in immune deficient mice showed that, in the absence of inflammation, islet destruction only occurred after reconstitution with activated T cells suggesting a prominent role of innate immunity in allorejection. The results also showed significant increase in M1 macrophage graft-infiltration following that of T cells during progression of acute rejection. We therefore hypothesize that intra-islet contact between T cells and macrophages leads to M1 phenotype through IFN-gamma signaling and promotes macrophage involvement in active islet destruction. We will test this hypothesis in our in vivo model with/without IFN-gamma receptor blockade. We will longitudinally (a) study interaction dynamics of labeled macrophages and T cells within islet grafts, (b) image macrophage activation during contact with T cells using Ca2+-signaling, (c) establish the macrophage phenotype using in vivo immunocytolabeling, and (d) image graft destruction/survival in real-time. The expected results from these aims will reveal novel local immune mechanisms underlying the role of macrophages in islet rejection. This will enable localized interventions to improve acceptance of transplanted islets in the treatment T1D and will help minimize/prevent devastating side effects associated systemic immunosuppression. The findings will also have broader implications in transplantation therapies in general, as well as, in cancer and autoimmune conditions.